Predoctoral Training in Molecular and Cellular Biology

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The goal of the Molecular Biology Program at the University of Colorado Anschutz Medical Campus is to train outstanding research scientists who will become future leaders in their chosen fields and disciplines. To accomplish this goal, we carefully select high-quality students with commitment, and passion for research. Our training program is flexible and student-oriented to meet individual needs, with a rigorous curriculum and high standards. Our Ph.D. in Molecular Biology is designed as a 5-6 year program with the first year devoted to challenging course work and laboratory rotations; the second to development of a research thesis; and the remaining to completion of the thesis research under the guidance of a training faculty mentor and thesis committee. To further develop their skills, students at all stages of the Program participate in weekly seminar series, an annual Symposium, and our Program retreat. Our curriculum emphasizes the development of critical and creative independent thinking, strong quantitative and statistical analytical skills with a focus on rigor and reproducibility and strong scientific communication skills. Our program’s close ties with the RNA Bioscience Initiative provide students with increased training in RNA biology, high-throughput DNA sequencing, and domain-specific bioinformatics training. A strength of the program is its outstanding and collegial faculty from 12 different departments and divisions who are deeply committed to graduate education and the MOLB Program. As the only NIH-supported training program on our campus focused on research into fundamental molecular and cellular mechanisms, faculty laboratories offer research opportunities for our students in multiple disciplines (biochemistry, genetics, immunology, cell, and structural biology), disease models (cancer, autoimmunity, infectious disease, and developmental disorders), and organismal models (viruses, bacteria, yeast, ciliates, flies, worms, and mice). The success of our training program is evinced by student publications and high-quality postdoctoral, faculty, and industry positions obtained by our students. Given the depth and quality of our student pool and our demonstrated ability to train high quality students, we request 10 students be supported each year.

Public health relevance
Narrative The future of biomedical and molecular biological research in the U.S. is dependent on the training of high quality, passionate PhD scientists who have learned to think critically and independently. The Molecular Biology Program at the University of Colorado Anschutz Medical Campus fosters the development of critically minded, dedicated researchers who can communicate effectively, investigate across disciplinary boundaries, and understand the human health implications of their studies.